Quantitative MRI and Network Science Applications in Manganese Neurotoxicity

Abstract: The welding industry in the US exposes over 600,000 workers to toxic welding fumes, including the
neurotoxic metal manganese (Mn), which can cause manganism, a condition with psychological, cognitive, and
motor deficits similar to Parkinson's disease. While effects of inhalation exposure to Mn and accumulation of
brain Mn in welders have been studied widely, most (if not all) studies tend to exclude the contributions of iron
(Fe), which competes with Mn for the same metal transporter for uptake into the brain. Information about the
effects of excess exposure to both, Mn and Fe, is still scarce and unclear. Some studies indicate that excess of
both metals could enhance metal-associated toxicity, while other evidence suggests that co-exposure to Mn and
Fe appears to counteract oxidative stress from each other. Recent advances in magnetic resonance imaging
(MRI) allow for the separate visualization of manganese and iron deposition in the human brain. More specifically,
multiparametric quantitative MRI (qMRI) techniques surpass the limitations of conventional imaging by
determining tissue parameters quantitatively. The advantage of this quantitative approach is the ability to better
disentangle Mn and Fe depositions and identify how regions of high Mn or Fe deposition may correlate with
specific symptoms of manganese neurotoxicity. To address the current knowledge gap on the relationship
between high chronic exposure to Mn and Fe, and the onset of neurologic dysfunction, this research aims to
develop methods that combine qMRI and network science to better understand the brain’s mediation mechanism
to excess metal accumulation and distribution, and neuropsychological changes associated with these
processes. This will ultimately enable non-invasive measurements to support early diagnoses, monitor metal-
related disease progression, and assess therapeutic responses. Our long-term goal is to use this newly acquired
knowledge to establish feasible clinical screening tools to diagnose and prevent adverse health effects due to
exposure to toxicants in the environment. To test the central hypothesis that quantitative MRI (qMRI) can quantify
changes in Mn and Fe deposition separately, the specific aims of the proposed study are: 1) To visualize and
quantify subject-specific excess brain Mn and Fe deposition using qMRI imaging and 2) To characterize the
brain’s mediation mechanism to excess metal accumulation and its association with neuropsychological
outcomes. Our project will have a significant translational impact by expanding the scope of innovative imaging
technology to other fields interested in assessing the spatial and temporal distribution of MRI contrast-enhancing
toxic metals such as chromium and gadolinium. Furthermore, these findings may guide policies on establishing
safe exposure limits for airborne particles to ensure safe and healthy working conditions for welders.

Public health relevance
PROJECT NARRATIVE --------------------------------------------- -------- ---- The signs of manganese (Mn) toxicity are neurological and range from mood, cognitive to motor disorders; thus, it is critical to understand how excess metal deposition from welding fumes affects different brain regions, and how these depositions are related to each other. Therefore, the goal of this research is to establish novel computational in vivo imaging methods to a) separately visualize and quantify excess Mn and Fe deposition in the individual welder brain, and b) characterize the propagation of Mn and Fe in the human brain and the role of different brain regions in the development of neurotoxicity effects with the aid of brain network science tools and advanced statistical methods.